Methodological Development

We continue to develop and employ novel methods aimed at measuring, describing and modeling social networks. During the current reporting period, we published a novel framework for modeling small network systems, such as families. This innovation allows for addressing questions related to how endogenous features of the network shape network structure. Our current work contributes to both theoretical innovation and methodological advancement in studying interconnected personal networks arising through multi-informant social network approaches.